The Role of Lipids in Obesity-mediated Protection in Sepsis

TITLE: The role of lipids in obesity-mediated protection in sepsis
ABSTRACT
Sepsis is an important clinical problem for which no specific therapies are currently available. Clinical studies
indicate that obesity is paradoxically associated with improved survival in sepsis; however, as obesity is a risk
factor for a wide variety of pathologies, it cannot be recommended as an option to protect against sepsis. It is,
therefore, important to understand the underlying mechanisms that lead to obesity-mediated protection in sepsis
as a step towards the development of novel therapeutic approaches. In this study, we will utilize existing clinical
data and biospecimens derived from sepsis patients to explore a connection between metabolic adaptation and
obesity-mediated protection in sepsis. In Specific Aim 1, we will evaluate the association between obesity status
and plasma lipid levels during sepsis using existing clinical data and plasma samples from the ARDSNet-SAILS
clinical trial. In Specific Aim 2, we will determine whether plasma lipid levels influence sepsis outcomes by first
correlating plasma lipid levels with major sepsis outcomes such as mortality, length of hospital stay, organ
dysfunction, and related biological/physiological variables. Additionally, we will investigate whether the protective
effect of obesity in improving sepsis survival is abolished with the lipid-lowering drug rosuvastatin. The long-term
goal of this work is to identify parameters related to obesity-mediated protection in sepsis, which can be further
mechanistically investigated and lead to the development of potential therapeutic interventions for sepsis.

Public health relevance
PROJECT NARRATIVE Obesity is paradoxically associated with improved survival during sepsis and other critical illnesses; however, the mechanistic basis for this protection is not understood. This project will investigate whether circulating lipids, which are elevated in the obese, are associated with improved outcomes in sepsis patients. The obtained data will allow for future mechanistic studies to further understand the processes at play.